Protein and redox homeostasis in cancer development and therapy

PROJECT SUMMARY
Protein homeostasis (proteostasis) and reduction-oxidation (redox) balance are two tightly regulated and
mutually associated molecular events. They play crucial roles in many physiological/pathological conditions
including cancer. Disruption of proteostasis and redox balance is an effective approach to selectively kill
cancer cells. For examples, proteasome inhibitors such as Bortezomib (Velcade) are highly effective in
treating numerous cancers, and autophagy inhibitors are being actively pursued as anti-cancer therapeutics.
Many clinically effective chemotherapeutic agents such as arsenic trioxide can induce oxidative burst and cell
death, which is believed to contribute, at least in part, to their anti-cancer effectiveness. On the other hand,
dysregulated proteostasis and redox homeostasis can contribute to oncogenesis by activating numerous pro-
survival/growth signaling pathways. The seemingly paradoxical effects (pro- and anti-cancer) are generally
thought to be accounted for by the intensity and duration of the stresses, although the precise underlying
mechanisms remain largely elusive. The ubiquitin-binding protein, p62 (SQSTM1), among its numerous
functions, critically regulates both proteostasis and redox balance, by sequestering certain proteins in
aggregates and delivering them to autophagosomes for degradation. This sequestration function of p62 relies
on its dimmerization via the hydrogen bond between lysine (K)7 and aspartate (D)69 residues. We recently
reported that TRIM21 (Tripartite motif-containing protein 21), a RING domain-containing ubiquitin E3 ligase,
directly interacts with and ubiquitylates p62 at K7 via K63-linkage, which abolishes the K7-D69 hydrogen bond
and inhibits p62 oligomerization, aggregation, and sequestration functions. One of the client proteins
sequestered by p62 is Keap1, a negative regulator of the antioxidant response that suppresses the antioxidant
transcription factor Nrf2. TRIM21-mediated p62 K7 ubiquitylation leads to the failure of Keap1 sequestration
and suppressed antioxidant response. Conversely, TRIM21-deficient cells display increased p62
oligomerization, protein aggregation, Keap1 sequestration, Nrf2 activation, and antioxidant response. In this
project, we propose to study the hypothesis that TRIM21 functions as a stress-adaptation molecule and plays a
crucial role in proteostasis and redox homeostasis, by ubiquitylating p62 and negatively regulating its
sequestration function, for the underlying mechanisms and biological significance, with a main focus on anti-
cancer therapy and oncogenesis. As TRIM21 expression is dysregulated and correlates with prognosis in
numerous cancers, accomplishing this project will uncover TRIM21 as a new important regulator for cellular
proteostasis and redox homeostasis, and will help reveal the role of TRIM21 in cancer development and
therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE Redox and protein homeostasis play an important role in oncogenesis and anti-cancer therapy. Our study is designed to test the hypothesis that the ubiquitin E3 ligase TRIM21 plays a critical role in regulating the antioxidant and autophagy pathways. This will provide new molecular connection between cellular stress and tumor development and therapy resistance.